Recruitment Core

SUMMARY
The main goal of the Faculty Recruitment Core is to establish the necessary workforce to meet the mission of
PHSU of advancing the field in minority health and health disparities through competitive research. This goal will
be accomplished by recruiting highly competent research faculty in the targeted RCMI areas (Cancer
Biology/Oncology, Neurosciences, Infectious Diseases, Chronic Diseases, Human Genetics, and Data Science)
through the implementation of effective strategies and guidelines. These new faculty recruits must have the
necessary experience, potential, and expertise to secure mainstream funding from the NIH as other federal and
non-federal agencies. Furthermore, these faculty members are expected to significantly contribute and advance
in their respective disciplines through the development of highly visible peer-reviewed manuscripts and other
scholarly activities. The intention is to recruit a faculty member in FY1 and FY3 during the next five-year funding
cycle, 2024-2029. All positions will be open to National competition to recruit and retain the most promising and
talented investigators. We propose to target a pool of junior to mid-career faculty candidates with strong
professional credentials in our target areas. More importantly, these candidates must possess the necessary
expertise and experience to be competitive for mainstream funding (R-type of grants through NIH and other
mechanisms). The credentials of candidates will be assessed by a Faculty Recruitment Committee designated
by the corresponding Dean of each PHSU School, and approved by the Chancellor. Faculty Recruitment
Committees are comprised of faculty members from the different PHSU Schools (Medicine, Public Health, and
Behavioral & Brain Sciences) as well as key members of the staff. The committee evaluates the credentials of
the applicants, deliberates, and ranks the three top candidates. Candidates will be invited to PHSU for formal
interviews, and an employment offer will be issued indicating the duties of the position and an attractive
compensation package by the experience and training of the candidate. The recruitment package will contain
salary and fringe benefits according to the current salary policy, reallocation expenses , laboratory and office
space, accessibility to PHSU existing Core research facilities, and start-up research funds . These requested
RCMI funds will supplement the typical recruitment package offered by PHSU, for acquisition of key equipment,
research supplies, salary for a post-doctoral fellow or other key personnel, and specialized
consultants/collaborators, etc. Recruits will also benefit from the faculty development Core of this application.
After proper negotiations and acceptance of the terms, the selected candidates will be invited to initiate their
duties as regular employees of the institution. PHSU has recently developed policies intended to enhance the
retention of talented research faculty.